FASEB's The TGF-ß Superfamily Conference: Signaling in Development and Disease

Abstract The FASEB SRC TGF-β Superfamily: Signaling in Development and Disease Conference in 2021 (hereafter “TGF-β 2021”) will bring together investigators who are leaders in a variety of interconnected and interrelated disciplines that intersect through a key role of TGF-β signaling in the process. Bringing together such a diverse group of scientists is essential for a comprehensive understanding and assessment of the TGF-β signaling axis in development, homeostasis, regeneration, aging, injury, and disease. The scientific presentations, formal and informal discussions, and poster presentations throughout the conference are designed to expand the understanding of the genetic, molecular and cellular mechanisms and processes by which the TGF-β signaling axis influences development and maintenance of organ systems, and to uncover how deregulation of this control results in disease. This knowledge is fundamental to understand how TGF-β signaling pathways are regulated and how they execute their functions under normal conditions in restoring the homeostasis of the body and facilitating successful tissue repair and regeneration. TGF-β 2021 will leverage new and important findings and provide attendees with: a broader appreciation and perspective of the complexity of the TGF-β signaling axis; examples of therapeutic strategies being tested and opportunities for considering and discussing future ones. This is the 11th FASEB TGF-β conference. The field of TGF-β signaling has been rapidly advancing and expanding; in particular, almost 10,000 articles per year related to TGF-β/BMP/GDF/Activin/Nodal have been published in the past five years. This fast pace warrants the convening of this conference and ensures its success. TGF-β 2021 takes pride in the strong tradition of collegiality of conference attendees and, most importantly, the collaborations that are generated through this conference. The collective experience built over the previous ten conferences has provided us with the confidence that TGF-β 2021 provides a forum for extended discussions and conversations, interactions, networking, debating of novel hypotheses and prioritization of unmet research or therapeutic needs, and career training/advice particularly for young investigators and trainees who represent future researchers in this field.

Public health relevance
Project Narrative TGF-β family signaling pathways act as central mediators of embryonic development, organ homeostasis, and the body's ability to repair successfully after injury. Importantly, perturbations in the TGF-β signaling axis are linked to a long and growing list of diseases of cardiovascular, respiratory, and skeletal systems, a multitude of cancers, and physiological changes during aging, providing fertile ground for the identification of novel targets and promising new therapies that can fundamentally impact the health of a broad segment of the population. The 2021 FASEB SRC TGF-β Superfamily Conference: Signaling in Development and Disease aims to exploit these exciting discoveries and provide a timely and relevant forum for their presentation, appreciation, analysis, and discussion to inspire and stimulate progress toward ever more effective and targeted therapeutics for TGF-β signaling disorders, while promoting the career development goals of participants, particularly those who are early career scientists, new to the TGF-β field, and/or members of underrepresented groups.